DP24-081 The Glaucoma and Retinopathy Screening Study

Project Summary
Glaucoma is the second leading cause of blindness in the United States, with over half of those with glaucoma
unaware that they have it. Underserved minority populations are at even higher risk of being undiagnosed,
leading to severe health inequities. Glaucoma is asymptomatic mainly in the early stages when vision loss and
disability can be prevented and, therefore, is only recognized by someone with the disease after permanent
severe vision loss is noticed. Glaucoma is an excellent candidate for early detection since effective and timely
treatment can arrest or delay loss of visual function. The relatively low prevalence of glaucoma, the high cost,
and the low specificity of existing diagnostic approaches, such as clinician evaluation, have limited widespread
early detection, which has been successful, for example, for diabetic eye disease.
Recent improvements in the accuracy of autonomous AI diagnosis of glaucoma, in combination with improved
ease of use and accuracy of virtual perimetry, offer novel technological breakthroughs that can be applied to
screening for glaucoma. Building on an increasingly widespread infrastructure of autonomous AI for diabetic
eye disease (that uses the same patient images), this novel glaucoma screening strategy could significantly
change this equation for the better, especially for currently underserved populations that are at the highest risk
for glaucoma. Implementing such a program would likely be cost-effective and improve health equity. We
hypothesize that people in high-risk communities with diabetes undergoing point-of-care, real-time autonomous
AI for diabetic eye disease (DED) are an ideal at-risk population to also screen for glaucoma, using a
combination of fundus photograph-based autonomous AI and virtual perimetry for suspect patients. This
efficient system using AI diagnostics as the initial screening followed by confirmatory screening with perimetry
evaluation will reduce over-referral, allowing for a scalable model with the potential to reach all individuals
undergoing screening for DED as well as others without diabetes who could be screened for glaucoma using
our approach.
We will add screening for glaucoma to DED screening in four United Against Racism primary care clinics in the
Boston area with strong representation of at-risk populations. We will screen 2000 individuals over this study
and, assuming a 10% prevalence of glaucoma will identify 200 individuals with glaucoma. We will determine
optimal strategies for adding this screening to eye screening programs nationally and will determine the cost-
effectiveness of the screening by comparing outcomes of those screened for glaucoma to outcomes of those
undergoing DED screening without being screened for glaucoma. The model will be scalable.

Public health relevance
Project Narrative Glaucoma is the second leading cause of blindness in the United States, with over half of those with glaucoma unaware that they have it, especially underserved minority populations. We will screen for glaucoma using innovative autonomous AI-grading of retinal photographs already being obtained to identify diabetic eye disease in community clinics serving at-risk populations. The project will track the outcomes of these individuals and compare these to those of individuals undergoing diabetic eye disease screening who are not being screened for glaucoma to determine the costs and benefits of the program.